CYCLE-AD: Randomized Controlled Trial to Assess the Efficacy of Indoor Cycling in Slowing Disease Progression in Healthy Older Persons at Genetic Risk for Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
The CYCLE-AD (Cycling to Cease or Limit the Effects of Alzheimer’s Disease) is a randomized controlled trial
(RCT) that was funded on January 15, 2021, for 5 years (end date: December 31, 2025). The overall goal of
CYCLE-AD is to assess the efficacy of home-based cycling exercise intervention in slowing disease
progression in 150 healthy older persons at genetic risk for Alzheimer’s Disease. The original grant proposal
was designed to recruit all participants from the metropolitan Cleveland area. We began recruitment in October
2021 intending to complete enrollment by the end of April 2024. Midway through the recruitment process, it
was realized our recruitment goal would not be met if recruitment was restricted to the metro Cleveland area.
We decided to conduct a nationwide search for participants meeting the inclusion criteria. Nationwide
recruitment has been successful and will result in enrollment completion by July 2024. The original budget,
however, did not include the additional travel costs associated with a nationwide search. In this proposal, we
are requesting supplemental funding to cover the travel costs associated with the nationwide
recruitment. The specific aims, research design, and methods of the current parent project, CYCLE-AD, have
not changed.

Public health relevance
PROJECT NARRATIVE This project will determine the disease-altering properties of high-intensity exercise by randomizing 150 cognitively intact, sedentary elders (ages 65-80 years) at genetic risk for Alzheimer’s disease into two groups: one engaged in a high-intensity home-based cycling program and the other engaged in their habitual level of physical activity. Both groups will be monitored over 18 months with cognitive testing and MRI brain scans serving as primary outcomes to determine the disease-altering characteristics of aerobic exercise. Successful translation and demonstration of the effectiveness of a scalable home-based exercise intervention capable of slowing disease course will transform AD treatment, improve patient outcomes and quality of life, and reduce healthcare costs.